Molecular determinants of condensate assembly in heterogeneous environments

Project Summary
Biomolecules, including proteins, nucleic acids, and metabolites, must first colocalize in order for biochemical
reactions to take place. As a result, spatially organizing biomolecules inside of living cells is a crucial require-
ment for a wide variety of biological processes. Whereas traditional organelles utilize membranes to accomplish
this task, more recently discovered biomolecular condensates instead achieve spatial organization via phase
separation—a thermodynamically driven process that causes immiscible fluids to demix spontaneously. Over the
past decade, an increasingly large number of biomolecular condensates have been discovered and implicated
in essential biological functions including gene transcription, protein synthesis, and cell signaling. Biomolecular
condensates are also believed to play roles in numerous pathological conditions, including neurodegenerative
diseases and viral replication. Understanding the biophysical mechanisms that control the stability, molecular
compositions, and assembly pathways of intracellular biomolecular condensates is therefore of critical impor-
tance. However, fundamental questions regarding the regulation of these structures—particularly in the hetero-
geneous intracellular environment—remain unanswered.
My research program uses theoretical and computational methods to uncover the molecular determinants of
biomolecular condensate compositional control and assembly mechanisms. Our approach to these fundamen-
tal biophysical problems leverages our unique expertise in combining molecular simulation, optimization theory,
and machine-learning strategies, and builds on our recent successes developing predictive theories of multi-
component phase separation and self-assembly kinetics. Over the next five years, we will focus our efforts on
answering two key biophysical questions underlying intracellular condensate assembly. First, to understand how
protein/RNA condensates can perform distinct biological functions in heterogeneous environments, we are de-
veloping computational models to map mixtures of protein/RNA sequences to distinct condensate compositions.
Our innovative approach combines data-driven machine-learning models with optimization techniques, which
will ultimately allow us to design protein and RNA sequences to rationally manipulate condensate-based spatial
organization in vivo. Second, to understand the mechanisms by which certain nuclear condensates assemble
at specific locations on chromatin, we are developing simulation models to predict the nucleation pathways of
chromatin-associated condensates. Our simulation strategy will provide essential insights and quantitative pre-
dictions of how histone modifications and transcription factors regulate the assembly of chromatin-associated
condensates. Our approaches to these questions emphasize experimentally testable predictions, and we are
working closely with experimental collaborators to validate the results of our models. In this way, our theoretical
and computational studies will advance the state-of-the-art in biomolecular condensate research, and also pave
with way for therapeutic applications based on manipulating this form of intracellular spatial organization.

Public health relevance
Project Narrative Biomolecular condensates are intracellular structures that organize cellular components into “membraneless organelles,” which play essential roles in a wide range of biological processes including gene transcription, protein translation, and cell signaling. This research program will determine the biochemical features of protein/RNA molecules that govern the molecular compositions and assembly mechanisms of biomolecular condensates, allowing us to connect changes in protein/RNA sequences to changes in membraneless compartmentalization within the complex intracellular environment. By leveraging modern simulation and machine-learning methods, our work will (1) provide vital insights into the mechanisms that cells use to control condensate assembly and composition, (2) introduce sequence design tools for engineering protein/RNA molecules to regulate condensate assembly and composition, and (3) lay the groundwork for future therapeutic strategies based on manipulating this form of intracellular spatial organization.